Partnerships for Prevention: A plan for managing student stress, anxiety, and pain through interactive media.

Pain, anxiety and stress are incidental to everyone’s daily life. For children and teens, learning how to
navigate these challenges is critical to establishing a sustained healthy lifestyle, yet little is done to directly
address these challenges in the typical school setting. Lacking the skills to manage stress, anxiety and
everyday pains of bumps and bruses is often disrupting to all aspects of children’s lives, placing them at risk of
falling behind in school, sports, extracurricular activities, and healthy social interactions. While millions of
children struggle, some children are clinically referred. For example, the CDC estimates that 2.6 million
children in the US aged 6-17 years have diagnosed anxiety, and studies show that the number of children
affected is increasing. In the worst case, failing to address pain, anxiety and stress can lead to substance
abuse involving opioids and tragedy. Our hypothesis is that attitudes toward pain, anxiety and stress can be
influenced by narrative-based educational stories for children in late elementary and middle school, helping to
set up healthy behaviors now and for later in life. Within a story, we plan to combine examples of situational
experiences that show the reader they are not alone in what they feel with illustrations of the fundamental
biology underlying the physiology and neural mechanisms of stress, anxiety and pain. The stories will then
reveal research-backed non-pharmacological-based pain relief and coping strategies (e.g., mindfulness,
stretching, strengthening, relaxation, ice packs, etc.) and how they can serve as the first line of defense,
helping individuals to listen to their bodies to understand what they can control and when to seek medical
advice. This integrated approach will be addressed by developing a collection of narrative-based interactive
ebook apps using an iOS/Android platform that we invented called BiblioTech™ Adaptive Reader™.
BiblioTech is a user-centered format that lets readers craft their own story by choosing where the characters
go and what they learn by interacting with a branched build-your-own adventure, complete with interactive
graphics, games, a digital notebook, and embedded video. With Adaptive Reader™ technology, the reader can
shift the text to be easier or more challenging, allowing for changes in vocabulary and sentence structure while
leaving the same learning goals intact. Digital note-taking engages the reader in scenarios and embedded
assessments where the reader demonstrates what they have learned, guiding where the story goes next.
Short videos will also be produced to complement the ebooks and to serve as an added resource. This
combined approach of apps, ebooks and videos serves both the student and the teacher, broadening the utility
across grades and individual reading proficiencies. Aligned curriculum will be developed for biology and health
sciences, along with teacher professional development workshops. Assessments and evaluations will be
conducted at various stages of development with late elementary and middle school students at suburban,
urban and independent schools. Students and teachers will be engaged in the development of story arcs.

Public health relevance
Everyday pains, anxiety and stress are facts of life that most of us learn to manage and deal with, even though they are never addressed in school. However, some of us struggle to cope, and sometimes that struggle leads to addiction. As a program to help head off substance abuse and opioid addiction, we are developing digital media Adaptive Reader™ stories for late elementary and middle school children that address both the biology of the nervous system and healthy management techniques, including mindfulness, for dealing with pain, anxiety, and stress.